Defining brain pericytes as a novel and myeloid-derived HIV reservoir

ABSTRACT
HIV-1-infected individuals are at a higher risk for non-AIDS related co-morbidities, including cerebrovascular
and neurological diseases. These pathologies may be driven, at least in part, by low levels of viral replication
that persist in HIV-infected brains, which can lead to immune activation, chronic inflammation, and viral
reactivation. Experiments on microglia, astrocytes, and brain pericytes indicate that these cells are all capable,
to different degrees, to harbor HIV infection. We have pioneered research on HIV-1 infection in brain pericytes,
and indicated that these cells possess the receptor profile enabling HIV-1 infection. Recent evidence on
pericyte ontogeny identified that a substantial subpopulation of brain pericytes originates from myeloid
progenitors. We recently demonstrated HIV-1-infected pericytes in human brains with HIV encephalitis.
Furthermore, our new and exciting preliminary data suggest that brain pericytes may be capable of latent
infection and reactivation, similar to other myeloid cells. Based on these observations, we hypothesize that
brain pericytes are a key, albeit previously unrecognized, cell type for the formation of HIV-1
reservoirs in the CNS. The overarching goal of the current proposal is to characterize the latent HIV-
1 infection in brain pericytes as the necessary step for successful eradication of CNS reservoirs and
HIV cure. Consistent with this goal, Specific Aims will evaluate the formation of latent HIV infection in brain
pericytes both in vivo and in vitro. In a cohort of human brain samples with a history of achieved viral
suppression obtained from the National NeuroAIDS Tissue Consortium (NNTC), we will determine whether
brain pericytes harbor latent HIV-1 infections in HIV-suppressed patients (Aim 1). In addition, we will evaluate
transcriptional signatures of latently HIV-1-infected human primary brain pericytes (Aim 2), and delineate
functional outcomes associated with HIV infection of brain pericytes (Aim 3).
The focus on the role of pericytes in the development of viral brain HIV reservoirs is an innovative and cutting-
edge conceptual approach, consistent with the current RFA. Focusing on pericytes as a novel myeloid cell
population in the context of HIV-1 infection and brain reservoirs has also a paradigm-changing potential and
is likely to lead to new discoveries in the field. The planned experiments will help us to better characterize the
pericyte reservoirs in the CNS in order to design future therapies for reservoir clearance and HIV cure.

Public health relevance
PROJECT NARRATIVE Identifying cellular reservoirs contributing to HIV-1 persistence is essential for development of curative strategies for HIV-1. This application is based on the central hypothesis that brain pericytes are a key, albeit previously unrecognized, cell type for the formation of HIV-1 reservoirs in the CNS. The proposed experiment will define whether brain pericytes harbor latent HIV-1 infections in HIV-suppressed patients (Aim 1), evaluate transcriptional signatures of latently HIV-1-infected human brain pericytes (Aim 2), and determine functional outcomes associated with HIV-1 infection of brain pericytes (Aim 3). Overall, the obtained results will help us to better characterize the pericyte reservoirs in the CNS in order to design future therapies for reservoir clearance and HIV-1 cure.